Clinical Research in ALS & Related Disorders for Therapeutic Development (CReATe) - Career Enhancement Core

Project Summary / Abstract
Career enhancement of junior faculty (both MD and PhD) has been a priority for the CReATe Consortium
through its first cycle of funding, with our CReATe Scholars being successful in securing extramural funding,
publishing results in high impact journals, securing junior faculty positions, and emerging as leaders within the
Consortium and more broadly within the field. The goals of the CReATe Career Enhancement Core are to
identify and select the most promising candidates who wish to pursue a career in rare disease research
focused on ALS and related disorders; provide these CReATe Scholars with support, opportunities and an
environment that is conducive to their successful career growth; and synergize the career enhancement
activities of the CReATe Consortium with those of the Rare Diseases Clinical Research Network (RDCRN) and
the neurological/neuroscience community more broadly. To these ends, we will provide each CReATe Scholar
with an array of training, mentorship, resource and partnership opportunities, and empower each Scholar to
tailor their career enhancement program to match their own unique needs. Available opportunities will include:
(1) didactics, leveraging existing programs through the National CTSA program, NINDS Network of Excellence
in Clinical Trials, NINDS Clinical Trials Methods Course, the RDCRN R25 Rare Diseases Certificate Program,
and RDCRN Clinical Conference on Research in Rare Diseases; (2) mentorship, both local and remote; (3)
networking, including opportunities for visiting rotations with investigators at other institutions; (4) travel
stipends, to enable participation and presentation of results at national and international meetings; (5) access
to CReATe resources (data repository, biorepository, St. Jude Cloud, etc.) as well as those of our partners
such as Target ALS (e.g. human tissue core); and (6) participation in patient advocacy group and other
strategic partner initiatives such as ALS Advocacy Day, scientific review committees, and patient support
groups. The significance and impact of our training program will ultimately be judged by the career trajectories
and accomplishments of the physician investigators and translational scientists whom we train.